Targeting p21-Highly Expressing Cells to Increase Lifespan and Healthspan in Old Age

Project Summary
Chronological age is the leading risk factor for most chronic diseases, frailty, and mortality worldwide. Thus, the
elderly population usually has multiple chronic conditions at the same time, resulting in poor health and reduced
quality of life (prolonged morbidity period) at the later stage of life. There is a big challenge to compress morbidity
period and increase healthspan (lifespan with good health). In this project, we propose to examine the role of
p21high senescent cells in lifespan and healthspan. We have generated and validated a new p21-Cre transgenic
mouse model containing a p21 promoter driving a bicistronic message consisting of Cre fused to a tamoxifen-
inducible estrogen receptor (ER) element. This model enables us to monitor, sort, kill or modulate p21high cells
with aging in vivo. Our preliminary data shows that p21high and p16high cells are two distinct cell populations, and
the p21-Cre mouse model targets 1.5-10% of cells in various tissues in 23-month-old mice. Monthly clearance
of p21high cells in mice starting at 20 months reduces frailty index, extends lifespan, and more importantly,
improves physical function at the end of life. In this proposal, we will further characterize the role and mechanisms
of p21high cells in lifespan and healthspan. Our overarching hypothesis is that targeting p21high cells can extend
lifespan and compress morbidity in old age. In aim 1.1, we will investigate whether clearance of p21high cells
could extend lifespan and healthspan using a larger group size. We will examine potential sex difference and
perform postmortem pathological analysis to examine the cause of death and disease burden. Moreover, we will
follow physical function and frailty index of these mice every month from 20-month-old to the end of life to assess
late life health status. In aim 1.2, we will leverage p21-Cre mouse models to sort and enrich p21high cells from 6
tissues of 23-month-old mice where we observed p21high cells (2-10%), and perform single cell RNA sequencing
on these cells along with non-p21high cells. In addition, we will perform single nucleus sequencing and imaging
mass cytometry. In aim 2, we will investigate the role of NF-κB pathway in p21high cells in lifespan and healthspan
shortening. This project is likely to have a broad impact on aging research by gaining a comprehensive
understanding of p21high cells at both functional and transcriptomic levels in vivo. Results from this project will
also enable future testing of pharmacological interventions that eliminate these cells to improve lifespan and
compress morbidity.

Public health relevance
Narrative A key challenge for the aging research community is to extend lifespan in tandem with healthspan (life with good health) so that the period of frailty and disability can be compressed. Here, we propose to examine the role of a specific cell population in lifespan and healthspan using our novel animal model along with a cutting-edge technology, single cell transcriptomics. This project is likely to provide a deeper understanding of aging and lay the foundation for the drug development to extend both lifespan and healthspan in old population.